Investigate interactive roles of environmental, behavioral and genetic factors on racial disparities in breast cancer outcomes

Project Summary:
Health disparities exist widely in the breast cancer outcomes (incidence, survival, and quality-of-life). When
compared with white women, African American women have higher recurrence and death rates from breast
cancer although they have a lower incidence rate. It is well established that both community and individual level
risk factors play important roles in breast cancer outcomes. In our previous studies, we have developed a
mediation analysis method to identify new biomarkers that contribute to health disparities in triple-negative breast
cancer (TNBC). We also developed a new multilevel mediation analysis method that allows for longitudinal
assessments of both residential environments and individual risk factors to be jointly utilized in determining the
mechanistic link between race and health outcomes. By including measures of individual and environmental
factors, our methods are capable of explaining existing disparities in health outcomes.In this project, we aim to
utilize the comprehensive database collected by the All of Us project to investigate the observed racial disparities
in breast cancer outcomes. Using the novel multilevel mediation analysis method, we will identify modifiable
factors that can explain the racial disparities observed in breast cancer outcomes. The risk factors to be
considered include measures at both the environmental (e.g. pollution measurements) and individual levels (e.g.,
smoking behavior and gene expressions). The information will help caregivers design precision medicine and
policymakers evaluate interventions that aim at improving treatment and reducing health disparities. We have
implemented our method as an R package (mlma) to provide the research community with open access to
software for performing multilevel mediation analysis. We plan to further develop an API for an interactive web
implementation of the software so that all researchers can use the method without the programming requirement.

Public health relevance
PROJECT NARRATIVE: Triple-negative breast cancer (TNBC) is a problematic, aggressive, and unpredictable subtype of invasive breast cancer associated with a high systemic recurrence rate with lethal metastasis. Currently, there are very few effective drugs approved by the FDA for the treatment of patients with advanced TNBC. In this project, we will investigate the activity of an experimental compound named LG007 and determine its potential as a new drug candidate for the treatment of TNBC.